MORPHOLOGICAL DEFICITS IN SPECIFIC LANGUAGE IMPAIRMENT

DESCRIPTION (Adapted from the Applicant's Abstract): Children with specific language impairment (SLI) often show especially serious limitations in the use of grammatical morphology. These difficulties include problems with bound morphemes such as past tense and third person singular inflections, and function words such as articles and auxiliary verbs. The purpose of this project is to explore the possible bases of these grammatical morpheme limitations, and to examine how such limitations might hinder other limitations of these children's language development. To accomplish this general goal, the grammatical morpheme comprehension and production abilities of children with SLI will be examined across three languages: English, Swedish, and Spanish. Data from these different languages will be used to assess the relative adequacy of five recent accounts of grammatical difficulties in English- speaking children with SLI. Because the morphological properties of Swedish and Spanish differ from those of English in critical ways, they offer a clearer view of the contribution of factors that are confounded in English, thereby facilitating interpretation of the data obtained from the English-speaking children with SLI. Inclusion of these other languages will also permit a stronger test of whether problems in word order are related to deficits in grammatical morphology. An understanding of the source of these children's problems with grammatical morphology and the role these problems play in other areas of language should lead to more appropriate treatment procedures for these children.